Determining the Structure and Function of Newly Discovered Immune Systems

Project Summary
Basic research on newly discovered immune systems has led to the development of important molecular tools
for use in science and medicine. For example, eukaryotic antibodies are used to diagnose and treat disease,
prokaryotic restriction enzymes are used to manipulate DNA sequences in vitro, and prokaryotic CRISPR-Cas
adaptive immune systems are revolutionizing genome editing, gene therapy, and disease diagnostics.
Recently, several new immune systems have been discovered for which their function remains unknown. The
emphasis of this proposal is to determine the structure and function of two newly discovered CRISPR-Cas
adaptive immune systems with the primary objectives to (i.) fill gaps in our understanding of these biological
systems and (ii) provide the basic mechanistic knowledge necessary to develop these immune systems into
new life science tools. To better understand the function of these immune systems we are using cell-based and
biochemical assays, as well as structural methods such x-ray crystallography and cryo-EM. We hope to
determine how these systems identify their targets, how they distinguish self from non-self, and how their
distinct genetic differences (protein domains and genes) impact their function.
!

Public health relevance
PROJECT NARRATIVE Many different immune systems have been repurposed as valuable tools in science and medicine (e.g. antibodies and CRISPR). However, the mechanisms of many genetically diverse immune systems remain unknown, suggesting other valuable molecular tools may still be waiting to be discovered. This work aims to understand the structure and function of two different bacterial immune systems that have not yet been characterized, with the hope of identifying novel molecular tools for science and medicine.